Annual International Primary CNS Lymphoma Collaborative Group Meeting

DESCRIPTION (provided by applicant): Primary central nervous system lymphoma (PCNSL) is an extranodal variant of non- Hodgkin lymphoma (NHL) that is confined to the nervous system. The diagnostic and therapeutic approaches to PCNSL are different from those that are applied to other forms of NHL or to other brain cancers. The International Primary Central Nervous System Lymphoma Collaborative Group (IPCG) consists of specialists from multiple countries and disciplines dedicated to the study of PCNSL. The IPCG holds an annual scientific conference at the American Society of Hematology meeting in which various research topics related to PCNSL are discussed. An international expert on the topic under discussion is selected each year by an executive committee to chair the scientific conference. These meetings have led to multiple collaborative projects that have impacted the field and that have been published in the peer-reviewed literature. The annual IPCG meeting is a critical forum for generating new ideas and approaches to this unique form of brain cancer. PUBLIC HEALTH RELEVANCE: The International Primary Central Nervous System Lymphoma (PCNSL) Collaborative Group (IPCG) holds an annual scientific conference each year to review research progress and to generate new ideas on PCNSL, a type of non-Hodgkin lymphoma in the brain. The annual conference has been very successful in stimulating international collaboration among the many different specialists involved in the treatment of this type of lymphoma. These collaborations have led to clinical trials and new tools to study outcomes in this group of patients.

Public health relevance
The International Primary Central Nervous System Lymphoma (PCNSL) Collaborative Group (IPCG) holds an annual scientific conference each year to review research progress and to generate new ideas on PCNSL, a type of non-Hodgkin lymphoma in the brain. The annual conference has been very successful in stimulating international collaboration among the many different specialists involved in the treatment of this type of lymphoma. These collaborations have led to clinical trials and new tools to study outcomes in this group of patients.